Mentoring Patient-Oriented Research in Deep Lipid Phenotyping for Cardiovascular Disease

Project Summary
Dr. Anand Rohatgi is an Associate Professor in the Department of Internal Medicine/Division of Cardiology at
UT Southwestern Medical Center. He has established a successful and independent research program
focused on elucidating the role of HDL metabolism in cardiovascular disease. His experiences as an active
clinical cardiologist, translational researcher, and mentor have positioned him to be an ideal candidate for the
K24 Mentoring Career Development Award. His clinical focus on preventive cardiology and the management
of atherosclerotic disease have paved the way for a synergistic translational research program focused on HDL
metabolism and atherosclerotic CV disease and a passion for mentoring trainees and faculty. Dr. Rohatgi has
applied both epidemiologic and translational POR to this objective, resulting in a number of published
observations that have moved the field forward with respect to insights into pathophysiology and refinement of
HDL-related markers for risk prediction and as targets of therapy. This work has been supported by continuous
funding from the NIH/NHLBI (K08>R01), the AHA, and industry. He has also developed a significant
professional interest in mentoring trainees in clinical cardiovascular research and career development. The
K24 award will support Dr. Rohatgi’s scientific career activities by allowing him to engage in professional
development via coursework/training and execution of novel projects that will enhance the primary aims of his
R01 and support future independent funding. In addition to supporting scientific career activities, the K24
award will directly allow Dr. Rohatgi to pursue mentorship/leadership training and enhance his ability to more
deeply engage with specific mentees pursuing K and R01 awards and more broadly engage with all mentees
in cardiovascular training. The overall scientific aims of this proposal are to: 1) Determine the contribution of
genetic factors to variability in cholesterol efflux; 2) Identify circulating metabolites and proteins linked to
variation in cholesterol efflux; 3) Determine the miRNA cargo of HDL in those with low versus high cholesterol
efflux; 4) Assess the effect of distinct miRNAs identified in #3 on cholesterol efflux transporters and efflux; 5)
Among those with extreme elevation in HDL-C, determine the presence of genetic mutations known to
correlate with elevated HDL-C (SR-B1, CETP, LIPG) and Lp(a) levels; 6) Determine proteomic and lipidomic
signature and functionality of HDL fractions in those with extreme elevations in HDL-C stratified by presence of
genetic mutations and elevated Lp(a) levels; 7) Determine the relationship between HDL function measures
(cholesterol efflux, HDL particle number, Apo-AI) and high-risk coronary plaque assessed by coronary CT
imaging in low risk cohorts.

Public health relevance
Project Narrative Reverse cholesterol transport is a key mechanism preventing atherosclerotic heart disease. We are investigating the genetic and molecular basis of what drives reverse cholesterol transport to better identify novel strategies to reduce heart disease risk. This project will train junior investigators on using patient- oriented research to improve heart health.